Improving hepatocellular carcinoma mouse modeling by understanding the malignant potential and biology of liver cell subpopulations

PROJECT SUMMARY
Hepatocellular carcinoma (HCC) is the fastest growing cause of cancer-related death in the United States and
one of the leading causes of death in patients with cirrhosis – the end result of any chronic liver injury. HCC is
difficult to treat and outcomes have barely improved over the last 30 years, with 5-year survival under 20% and
an incidence-to-mortality ratio near 1. Innovative strategies for detection, prevention, and treatment for HCC are
desperately needed, the development of which will depend heavily on mouse models of liver cancer. The current
models are inadequate because they do not take into account the cells of origin, which will likely have a significant
impact on tumor initiation, maintenance, and therapeutic vulnerabilities. While the liver is appreciated for being
a central metabolic hub and for its astounding regenerative capacity, cellular heterogeneity in the liver is mostly
unexplored. Along the portal to central axis within the hepatic lobule, profound differences in gene expression,
metabolism, hypoxia, and ploidy are observed. Whether or not these differences reflect differences in neoplastic
potential, and whether or not they influence metabolic disease or carcinogenesis, is unclear. In recent years,
there has been intense controversy about whether or not there is a liver stem/progenitor cell. To compound these
debates, the injury assays used to drive HCC development often do not model common etiologies such as non-
alcoholic steatohepatitis (NASH), which is emerging as the most common cause of cirrhosis in the U.S. We posit
that a critical problem for HCC modeling is a lack of understanding of how different cell types contribute to cancer
in the context of clinically relevant injuries. We believe that identifying the specific cellular subtypes that give rise
to HCC and then being able to genetically perturb these cells is critical for us to better model HCC. Unfortunately,
the field does not have mouse reagents to manipulate much of the heterogeneity in the liver. To address this,
my lab has optimized CRISPR genome-editing methods to rapidly generate lineage tracing mice. Nine new
CreER knock-in models that label different zone-specific and progenitor populations have been produced,
effectively quadrupling the number of CreER lines available to our field. We will use these tools to trace and
genetically manipulate cell types in a systematic fashion in order to identify the most important regenerative cell
populations (Aim 1) and the HCC cell(s) of origin (Aim 2) in the context of clinically-relevant chemical and
nutritional injuries. We will then ask if cell type specific gene manipulation of common HCC driver genes will help
to uncover different transformation competencies between hepatocyte subpopulations (Aim 3). Success in this
project will provide the community with a large panel of important CreER tools, allow the field to focus on
important subpopulations that are more likely to transform, and reveal pathways that control tumor development
in these cells.

Public health relevance
NARRATIVE Hepatocellular carcinoma (HCC) is the fastest growing cause of cancer-related death in the United States and innovative strategies for detection, prevention, and treatment will depend heavily on mouse models. The current HCC models are inadequate because they do not take into account the biology of their cells of origin, a problem which we will address using lineage tracing and genetic manipulation experiments in a large panel of CreER mice we developed to label a broad range of specific hepatocyte subpopulations. Success in this project will provide the community with a large panel of important tools and allow the field to focus on important subpopulations that contribute to HCC biology.